Perceptual and Cognitive Mechanisms of Developing Fractions Knowledge: A Cross-Sequential Approach

Project Summary Mathematical competence is an important determinant of life chances in modern society, and knowledge of fractions is a foundational skill for establishing mathematical competence. Despite the importance of fraction knowledge, children and adults often encounter considerable difficulties understanding fractions. To explain these widespread difficulties, many researchers have argued for an innate constraints account. They propose that fractions are difficult because they do not correspond to any preexisting categories in our brain, unlike whole numbers, which correspond to sets of countable things. Thus, they argue fraction concepts are challenging because they do not benefit from existing cognitive abilities and instead must be learned through adapting children's whole number understanding. The study team proposes a competing hypothesis, the cognitive primitives account, which integrates previously unrelated findings from neuroscience, developmental psychology and education. We argue that a primitive ability that we dub the ratio processing system (RPS) is tuned to the processing of non-symbolic fractions—such as the relative length of two lines or the relative area of two figures—and is present even before formal instruction. On this view, children are equipped with cognitive mechanisms that support fraction concepts in the same way that the ability to process countable sets equips them to learn about whole numbers. To test the predictions of these competing hypotheses, this project will follow two cohorts of children (2nd graders until 5th grade and 5th graders until 8th grade) using behavioral and brain imaging methods to (a) trace the development of non-symbolic fraction processing abilities, (b) determine how symbolic fraction knowledge builds on these abilities and (c) investigate whether individual differences in the RPS predict later math achievement. To test whether the acuity or recruitment of these non-symbolic architectures plays a role in fraction difficulties as well as general math learning difficulties, the study team will compare the behavioral performance and neural activity on a battery of cognitive tasks. This research has important implications for our understanding of number processing and for designing educational practices that are optimal for fraction learning. Improving fractions understanding would help children to clear a critical hurdle in the acquisition of higher-order mathematical competencies that impact educational, employment, and even health outcomes. If cognitive primitives for non-symbolic fractions can provide a foundation for the acquisition of symbolic fraction ability, then instruction should attempt to recruit these primitives. If deficits in these primitives contribute to math learning difficulties, then screening should include measures of non-symbolic abilities and interventions should be designed to address these abilities.

Public health relevance
Project Narrative Mastering fractions is a critical step towards developing higher-order mathematical skills, but many children and adults struggle to learn and use them. This study will follow two groups of schoolchildren longitudinally between 2nd and 8th grade to investigate how basic perceptual abilities rooted in the human brain support the learning and use of fractions, and in turn, how fractions support higher-order skills like algebra. The results of this study will provide new insights into 1) the nature of human number processing, 2) the mechanisms by which fractions instruction has its effects, and 3) key individual differences that can help deepen our understanding of math learning difficulties and the potential for their remediation. By better understanding the origins of difficulties with fractions, we aim to improve math skills (and life outcomes) that depend on fractions understanding.